WORKER HEALTH AND SAFETY TRAINING COOPERATIVE AGREEMENT

DePaul University and its Consortium is responding to three components of the NIEHS Worker Health and Safety Training Cooperative Agreement Programs RFA: ES99-009: EPA-Hazardous Waste Worker Training (HWWT), EPA-Brownfields Minority Worker Training (BMWT), EPA-Minority Worker Training (MWT).